2024 Optogenetic Approaches to Understanding Neural Circuits and Behavior Gordon Research Conference and Seminar

Project Summary
The next Gordon Research Conference (GRC) on Optogenetic Approaches to Understanding Neural Circuits
and Behavior will convene in Lucca (Barga), Italy, on July 21-26, 2024. This will be the fourth time that this
international conference brings together the diverse community of scientists using optogenetics to interrogate
brain function with the overall goal of fostering an inclusive and collaborative environment for scientific
exchange. The optogenetics community is comprised of tool developers and users, experimentalists and
theorists, bioengineers, clinicians, and basic scientists. The optogenetics toolbox has rapidly expanded and
allows researchers to alter activity in genetically defined cell types and pathways, to mimic neurotransmitters
and neuromodulators and monitor the activity of intracellular processes. While such rapid progress in the field
has brought a wealth of tools and techniques into the hands of researchers, the field faces the challenge of
defining best practices and rigorous standards to ensure proper experimental study design and data
interpretation. These issues are of paramount importance as the field witnesses a transition from bench to
bedside with the translation of optogenetic tools to treat human disease. The Optogenetics GRC places as
much value on encouraging speakers to discuss details regarding techniques and implementation as it does on
highlighting exciting study outcomes. The major aims of the conference are to (1) expose participants to
emerging optogenetic tools, gene targeting approaches, and optical innovations, (2) highlight innovative
applications and translation of optogenetic approaches, (3) feature recent research innovations from junior
scientists, (4) support networking opportunities to enhance trainee learning, mentorship, inclusion, and
professional development. To meet these goals, the conference will feature a diverse platform of scientific
sessions that include keynote speakers and established investigators as well as junior investigators in the
earliest stages of their careers. Beyond the scientific sessions, the meeting will include dedicated mentoring
activities for junior investigators and a GRC Power Hour to discuss issues facing women and
underrepresented groups. The GRC will be preceded by a Gordon Research Seminar (GRS), which provides a
unique opportunity for junior investigators to engage in scientific discussion before attending the GRC.

Public health relevance
Project Narrative The 2024 Gordon Research Conference and Gordon Research Seminar on Optogenetic Approaches to Understanding Neural Circuits and Behavior will bring together leading experts and junior investigators, tool designers and tool users, experimentalists and theorists with the goal of fostering scientific exchange in the rapidly growing field of optogenetics. The conference program will provide multiple forums in which attendees will share unpublished results and discuss the latest technological developments, the strengths and limitations of the tools, and how they can be applied to addressing questions about brain and behavior and ultimately to treating human disorders. As such, the conference will serve to foster new ideas and collaborations and will propel the next generation of young scientists toward new applications and discoveries.